Administrative Supplement: Glutathionylated Products of Radical-Induced Lipid Oxidation in Inflammatory Disease

Abstract
An administrative supplement is requested for the repair of a key tool for the project, a triple
quad LC-MS/MS. This funding opportunity came just in time as this important equipment has been
broken for over a month. This instrument is needed for quantitative detection of products gener-
ated by free radical-induced lipid oxidation in the retina, e.g., pseudo leukotrienes (øLTs), and
structurally similar leukotrienes (LTs). Our primary tool for assessing øLT and LT generation
is LC-MS/MS with isotope dilution quantitation. Understanding the generation and cellular
responses to free radical-induced lipid oxidation products is complex owing to their diversity and
ability to mimic enzymatically generated receptor agonists, e.g., LTs. We discovered glutathione
(GSH) derivatives produced from oxidatively truncated arachidonyl phospholipids that are
structural and functional analogues of cysteinyl (Cys) LTs. We refer to them as øLTs. The project
is testing the hypotheses that øLTs contribute to retinal pathology and physiology in a rat model
of light-induced retinal degeneration. øLTs are present in human retina, are produced in vivo
consequent to oxidative insult, and exhibit LT-like biological activities. Therefore, øLTs can elicit
cellular responses erroneously presumed to be induced exclusively by CysLTs. Consequently,
they are a confounding factor for interpreting previous studies on the involvements of LTs in retinal
pathology and physiology. The research is testing the hypotheses that øLTs and related GSH
derivatives of oxidatively truncated docosahexaenoyl phospholipids contribute to receptor-depen-
dent inflammatory cytokine signaling, retinal edema, pathological neovascularization, or physio-
logically important initiation of retinal pigment epithelium (RPE) autophagy. The potential patho-
physiological significance of these glutathionylated products of lipid oxidation lies in the possibility
of their ubiquitous generation in high levels, e.g., compared to those of CysLTs. We are testing
the conclusion of preliminary studies that øLTs are LT receptor agonists and will determine if their
ability to induce the expression of IL-13 and TGF-b1 promotes LT biosynthesis. Because cross
reactivity may confound the interpretation of immunoassays for LTs, we must quantitate
both øLTs and LTs by LC-MS/MS. We will determine signaling pathways, e.g., with RNA-Seq
studies, activated by glutathionylated products of free radical-induced lipid oxidation addressing
the questions: do they promote inflammation in ocular pathology or initiate autophagy in RPE cells
and how do they do it? Molecular level insights into the role of oxidative stress in the pathogenesis
of inflammatory eye diseases such as AMD can facilitate development of therapeutic interventions
that ameliorate the progression of these common but disabling diseases.

Public health relevance
Project Narrative The proposed research focuses on understanding the pathological and physiological consequen- ces of our discoveries that lipid oxidation in the retina leads to the production of glutathione derivatives, pseudo leukotrienes (øLTs), that promote inflammation by masquerading as pro- inflammatory molecules including leukotrienes (LTs). These discoveries represent a mechanistic link between free radical-induced lipid oxidation and inflammation in the retina that contributes to age-related macular degeneration. The LC-MS/MS instrument to be repaired is needed for quantitative detection of øLTs and LTs.